Manipulating Stem Cells to Provide Long Term Regeneration of Irradiated Salivary Glands

PROJECT SUMMARY/ABSTRACT
Worldwide, the quality of life of over half a million surviving head-and-neck cancer patients per year is
drastically decreased due to co-irradiation of healthy saliva-secreting salivary glands. Current therapies to
rescue hypo-salivation only provide temporary relief; hence new therapies for permanent tissue repair are
needed. In a mouse model, we induced successful repair of irradiated salivary glands by transplanting KIT+
stem/progenitor cells. However, this population of stem/progenitor cells decreases with age and is
heterogeneous; hence, currently compromising our ability to efficiently use these cells for therapy. Recent
discoveries in our lab have shown that transcription factor SOX10 tightly regulates proliferation and
differentiation in fetal KIT+ cells. In this proposal we hypothesize that only a subpopulation of adult KIT+ cells,
which express SOX10, retain stem cell self-renewal capacity. Thus, we aim to: (1) characterize the multipotent
stem cells within the KIT+ cell population, (2) define the role of transcription factor SOX10 in maintaining adult
KIT+ cells, and (3) characterize the molecular heterogeneity and SOX10 signature in human KIT+ cells.
Overall, the scientific ideas proposed here will expand our knowledge of salivary gland stem cell populations,
and will significantly improve future hypo-salivation rescuing by stem cell-based therapies.

Public health relevance
PROJECT NARRATIVE Over half a million head-and-neck cancer patients suffering from irradiation-induced xerostomia are deprived of long-term therapeutics because, in part, not much is known about the mechanisms regulating the self-renewal of salivary gland stem/progenitor cells. This proposal aims to identify the molecular differences within the epithelial KIT+ cells and define the multipotent self-renewing stem cells within the KIT+ cell population. This work will facilitate stem cell-based therapeutics for rescuing hypo-salivation in head-and-neck cancer patients.